RI-INBRE CRCF Instrument Supplement

Project Summary
The Rhode Island IDeA Network of Biomedical Research Excellence (RI-INBRE)
program is to enhance the capacity for biomedical research at institutions and broaden
student training opportunities in Rhode Island. This is achieved through support for
faculty development and hands-on training with instruments. To further these goals, an
administrative supplement is being requested for funding of Monolith X instrument for
the RI-INBRE Centralized Research Core Facility (CRCF). The addition of Monolith X
will complement the existing Biacore T200 Surface Plasmon Resonance (SPR)
instrument and enable entry- and medium-level users to access experiment data easily
and fast. Additionally, the limited availability of Monolith X instruments in the state has
resulted in a bottleneck for the research community.

Public health relevance
Project Narrative The Instrument Supplement application funding will provide the RI-INBRE Centralized Research Core Facility (CRCF) with the opportunity to acquire a Monolith X instrument from NanoTemper Technologies. Monolith X will complement the facility's current Biacore T200 Surface Plasmon Resonance (SPR) system and provide entry and medium-level users with an efficient and expedited process for retrieving experiment results.